Neural mechanisms of anxiety during early and protracted abstinence in alcohol use disorder

Project Summary: Alcohol use disorder (AUD) is a chronic, neuropsychiatric illness characterized by frequent
relapses, driven in part by anxiety during abstinence. Identifying the neural mechanisms that underlie anxiety
during abstinence may identify targets for novel treatments. The aims in this proposal will train Dr. Srivastava
to be uniquely qualified to conduct this research. While pursuing this line of research under the guidance of
mentors who are recognized experts in clinical trials in substance use disorders and co-occurring psychiatric
illness (Frances Levin, MD), fMRI methodology (Gaurav Patel, MD, PhD), and addiction neuroscience and
psychophysiology (Nasir Naqvi, MD, PhD), Dr. Srivastava will engage in a comprehensive training program in
the following areas: 1) learning clinical trials methodology to conduct mechanistic research in AUD and co-
occurring psychiatric illnesses, 2) fMRI methodology, 3) addiction neuroscience and psychophysiology, and 4)
grant writing and management skills. This training will build upon Dr. Srivastava’s training as an addiction
psychiatrist who has significant experience treating AUD but relatively little experience in clinical research. To
facilitate this training, Dr. Srivastava will investigate how alterations in anxiety circuitry involving the bed
nucleus of the stria terminalis (BNST), anterior insula (AI) and dorsolateral prefrontal cortex (DLPFC) may
underlie anxiety during abstinence from alcohol and how this circuitry might change as a function of sustained
abstinence. This proposal combines 1) participants with AUD stabilized on disulfiram to facilitate abstinence,
2) functional MRI (fMRI) experiments that probe neural activity related to anxiety, and 3) psychophysiological
markers of stress and anxiety. AI-BNST and AI-DLPFC connectivity will be investigated using resting state
functional connectivity (RSFC), and AI, BNST, and DLPFC activations will be investigated using a threat
anticipation task. The fMRI studies will be performed between 1-2 weeks after stabilization on disulfiram order
to capture early abstinence and then after 12 weeks of treatment, with the goal of determining 1) if anxiety
circuit connectivity and task-evoked activation during unpredictable threat anticipation in early abstinent AUD
participants differ from healthy control participants, 2) if anxiety circuit connectivity and task-evoked activation
correlate with self-report measures of state anxiety during early abstinence, 3) if anxiety circuit connectivity and
task-evoked activation change over the course of abstinence, and 4) if changes over the course of abstinence
in anxiety circuit connectivity and task-evoked activation correlate with changes in self-report measures of state
anxiety. Thus, the K23 award will support an innovative and clinically relevant program of patient-oriented
research while training Dr. Srivastava in critical skills that will ensure his development into an independent
translational researcher who leads future studies on mechanisms underlying abstinence in AUD and co-
occurring psychiatric illnesses.

Public health relevance
Project Narrative: Alcohol use disorder is a debilitating neuropsychiatric illness that often presents with significant anxiety, increasing the risk of relapse. The overall goal of this K23 proposal is to launch the career of the Principal Investigator, A. Benjamin Srivastava, MD, as an independent translational researcher who can combine clinical and cognitive neuroscience methods in order to understand the neural mechanisms underlying anxiety during early and protracted abstinence in alcohol use disorder. Ultimately, this patient- oriented research program will lead to both improvements in diagnosis and the identification of new treatment targets aimed improving outcomes in alcohol use disorder and co-occurring psychiatric illnesses.